Innovations in Personalizing Treatment for Eating Disorders Using Idiographic Methods and the Impact of Personalization on Psychological, Physical, and Sociodemographic Outcomes

PROJECT SUMMARY/ABSTRACT
Eating disorders (EDs) are serious mental illness: someone dies of an ED every 52 minutes.
EDs are highly related to a host of negative outcomes, including public health and individual
disease burden, medical and psychological comorbidities, and social determinants of health
(SDOH). Treatment response for EDs are suboptimal; there are no evidence-based treatment
for adults with anorexia nervosa (AN) or Other Specified Feeding or Eating Disorder (OSFED)
and only 50% of adults respond to current evidence based treatments. There are no precision
treatments, nor any treatments that consider social context, in existence. Personalized
treatments for EDs, that consider social contexts, are urgently needed to improve treatment
response and minimize the suffering associated with these illnesses. Our overall goal, extending
upon our past work, is to create a treatment personalized based on idiographic (or one person)
models (termed Transdiagnostic Network Informed Personalized Treatment for EDs; T-NIPT-
ED). We will carry out a two-phase study to systematically characterize individual mechanisms
of treatment (Phase I: N=900) and then test the efficacy of each treatment module (Phase II:
N=240 drawn from Phase I) compared to the current gold-standard treatment (Cognitive
Behavioral Therapy Enhanced: CBT-E). Our study goals are to (1) characterize the prevalence
of T-NIPT-ED precision treatment mechanisms and medical and psychological comorbidities
(e.g., obesity; depression), individual disease burden (e.g., disability), SDOH (e.g., food
insecurity), and public health outcomes (e.g., service utilization) specific to these mechanisms,
(2) identify if personalized target mechanisms improve when matched to evidence-based
treatment modules of T-NIPT-ED and (3) test if change in T-NIPT-ED is associated with
improved outcomes (vs CBT-E), including ED outcomes, comorbidities, disease burden, and
public health outcomes and if these outcomes are moderated by SDOH. These goals will
ultimately lead to the very first precision treatment for ED and can be extended to additional
psychiatric illnesses. The proposed research uses highly innovative methods; intensive
longitudinal data collected with mobile technology is combined with state-of-the art idiographic
modeling methods to deliver a virtual, personalized treatment. This proposal integrates
assessment of broad (e.g., SDOH; public health burden) and specific (e.g., ED symptoms)
outcomes, to ensure that social context can be integrated into personalization. The proposed
research has high clinical impact. Ultimately, this proposal will lead directly to the creation and
dissemination of an evidence-based individually-personalized treatment for EDs, as well as will
serve as an exemplar for precision treatment development across the entire field of psychiatry.

Public health relevance
PROJECT NARRATIVE This project will build a new precision treatment for eating disorders and identify how individual treatment mechanisms relate to public health outcomes, individual disease burden, medical comorbidities, and social determinants of health. The proposed research has significant public health relevance, as it will directly lead to a highly accessible and deployable personalized treatment that can improve treatment response rates and be applied to all psychiatric illnesses. The proposed research is relevant to NIH’s strategic aim 3.3b, as it will lead to the creation of a personalized treatment consistent with NIH’s precision treatment initiative.